Supplement Proposal-A Pediatric Clinical Center for Molecular Transducers of Physical Activity (MoTrPAC): Towards a Molecular Map of Exercise in the Pediatric Origins of Health Across the Lifespan

BLANK PAGE
FOA PAR-20-272

Public health relevance
BLANK PAGE FOA PAR-20-272